HPLC MASS SPECTROMETRY

We have coupled a Michrome microbore HPLC instrument directly to our Finnigan TSQ-700 electrospray ionization mass spectrometers to allow us to perform on-line HPLC - mass spectrometry. We are continuing to evaluate and improve the performance of the system, and are currently evaluating the sensitivity that we can achieve with very narrow bone capillarly HPLC separations